Leveraging multi-omics for endotyping to identify subtypes and mechanisms of cardiometabolic diseases

Project Summary
Prior studies have identified several risk factors related to cardiometabolic diseases. However, the rates of risk
factor elevation are highly variable among patients. For example, despite obesity being identified as a primary
risk factor for cardiometabolic diseases, a subgroup of obese patients does not develop downstream
cardiometabolic complications. This suggests that there are other mediating mechanisms, independent of
known risk factors, underlying cardiometabolic diseases. This project will leverage multi-omics data in
conjunction with clustering approaches capitalizing on genome-wide association study (GWAS) data in BioVU,
GWAS and other omics data generated by the NHLBI Trans-Omics for Precision Medicine (TOPMed) program
and metabolomics data collected at 3 time points in a prospective cohort of bariatric surgery to identify: 1)
clusters of individuals that represent cardiometabolic diseases (defined as novel/endotypic determinants of
diseases), 2) endotypes of each cardiometabolic disease by clustering individuals within each disease
(determined as pathobiological mechanisms related to disease) and 3) endotypes of responsiveness to
bariatric surgery. To explore these overall study goals, the similarity network fusion method will be used along
with the consensus clustering approach. Specifically, this project aims to 1) create genetically predicted levels
of transcriptome, proteome and metabolome in 54,000 individuals in BioVU, use these predicted levels to
construct clusters of individuals and examine whether these clusters represent diseases using the BioVU
phenotype data, 2) construct clusters of individuals using direct measurements of multi-omics data
(transcriptome, proteome and metabolome) in over 5,000 individuals in TOPMed, construct genetically
predicted levels of the obtained clusters and impute them in BioVU using the BioVU GWAS data and explore
whether these predicted levels represent cardiometabolic diseases using phenotype data in BioVU and 3)
create metabolomic driven clusters using the plasma metabolomics data at baseline, 3 months and 12 months
post bariatric surgery in 104 patients, explore the association of the identified clusters with cardiometabolic
responsiveness and identify novel baseline metabolomic predictors of responsiveness to weight loss surgery .
The proposed study will leverage multilayered –omics data using a novel and innovative network modeling
analysis, providing Dr. Bagheri with critical skills, tools and experience to complete the research aims. This will
be achieved by the accomplishment of the following two training goals which will help her to become an
independent ‘big data’ cardiometabolic scientist: 1) gaining more in-depth knowledge of small molecule
metabolism in biologically-informed cardiometabolic disease subtypes and 2) gaining expertise and expand her
existing experience in bioinformatics and statistical multi-omics integration methods.

Public health relevance
Project Narrative Individuals who develop cardiometabolic diseases may not have elevations in risk factors suggesting that there are other risk mediators underlying diseases that are not yet identified. This project will use cutting-edge and innovative multi-omics approaches which examine many factors measured in blood to identify groups of individuals who are biologically similar and will determine whether the groups have different functional and/or pathophysiological risk mechanisms for disease or different response to treatments. These groups can be further studied to determine their risk mechanisms, and this will ultimately lead to new personalized ways of managing and preventing cardiometabolic diseases.